Predictive ability of early somatosensory processing in preterm children on later motor development

Project Summary
Children who are born preterm are at a high risk for developing sensorimotor deficits. Though a majority of
children born preterm do not have a neuromuscular diagnosis such as cerebral palsy, many have mild to
moderate motor delays. These motor delays fall under the diagnosis of developmental coordination disorder or
developmental dyspraxia, a condition with difficulties in motor planning and coordination, that is theoretically
linked to somatosensory deficits. We hypothesize that deficit in somatosensory processing may precede this
diagnosis in preterm children, but these deficits are not identified due to a lack of reliable and valid assessment
methods for use with young children.
Somatic sensations refer to sensory information from the body, including touch and proprioception.
Proprioception -- the sense that lets us know how and where our body is moving -- is considered one of the
most important senses for controlling movements. Based on research on motor learning in adults, we know the
importance of accurate proprioception information on the control of movements. Difficulties in somatosensory
information will impact a developing nervous system’s ability to learn new motor skills. This effect theoretically
compounds as the child learns more motor skills with inaccurate somatosensory feedback, laying a poor
foundation for further learning. However, our current understanding of how the sensory and motor systems
interact in a developing nervous system is limited.
The poor understanding of somatosensory in development is in part due to the lack of accurate assessments
that measure somatosensory processing in young children. Current somatosensory assessments are limited to
clinical observations and parent reports on the child’s behavior, which lack objectivity and do not provide a
standard for comparison. Without objective assessments of somatosensory processing in young children,
somatosensory processing deficits are often not identified until later in their childhood, when they present with
motor delays.
We developed and pilot tested innovative methods to measure somatosensory processing in children as young
as 1 year old. The overall objectives of this project is to study somatosensory development in young children,
develop a method to identify children who have challenges with somatosensory processing, and to examine
the predictive relationship between somatosensory processing challenges in early childhood with later motor
development. We hypothesize that somatosensory develop play a major role in predicting motor skill
development and participation in activities of daily living in children who were born preterm.
This study is part of a larger research program that aims to better our understanding of somatosensory
development in children. We strive for early identification of children with somatosensory deficits, and to
develop targeted interventions for these deficits in children.

Public health relevance
Project Narrative Children who are born preterm are at a high risk of development sensorimotor deficits, including developmental coordination disorder (DCD), one of the most common yet least studied developmental motor disorder. This study aims to investigate the predictive relationship between somatosensory processing deficits during early childhood in preterm children, and later motor development. Better understanding of the relationship between somatosensory deficits and motor development will allow us to identify children who experience these difficulties before they show significant motor delays and to develop tailored interventions for them.